The "olfactosome" as a biomolecular condensate

Summary
Biomolecular condensates (BMCs) represent an ingenious biological solution to the problem of organizing and
streamlining biochemical processes without generating distinct organelles. From P bodies in the cytoplasm to
the nucleolus and heterochromatic compartments in the nucleus, the assembly of nucleoprotein condensates
provides the means of efficiently co-regulating gene expression and mRNA processing and translation. Further,
stimulus-induced assembly of condensates at the cell membrane enhances the specificity and robustness of
signal transduction cascades. Thus, it is without doubt that BMCs play critical roles in neuronal functions and
that their misregulation contributes to neurodegeneration and other neurological disorders. Here, we take
advantage of the unique properties of the mammalian olfactory system to establish a powerful paradigm for the
rigorous dissection of BMC assembly and function in the nervous system. Specifically, we propose that the
“olfactosome,” the multi-chromosomal enhanceosome that assembles upon a randomly chosen olfactory
receptor (OR) locus, represents a BMC in which molecular crowding induces the activation of 1/2800 OR alleles.
To explore this hypothesis, we will take advantage of a recent technical breakthrough that allows us to culture
neuronal progenitors and to differentiate them into olfactory sensory neurons that express the same OR allele in
a singular fashion, ex vivo. With this remarkable tool, we propose to genetically label the nascent OR RNA, the
converging inter-chromosomal enhancers, and the proteins residing in the olfactosome. Then, we will perform
live imaging single particle tracking (SPT) experiments that will determine the kinetic properties of the
nucleoprotein components of the olfactosome inside and outside this multi-enhancer hub and at variable nuclear
concentrations. Our experiments will provide mechanistic insight to a regulatory process that is essential for the
function of olfactory neurons and for sensory perception, and will generate widely applicable principles for the
role of molecular crowding in highly cooperative transcriptional processes. Importantly, with the emerging role of
olfactory deficits in a plethora of pathological human conditions, from COVID-19 infection to Alzheimer’s disease,
which according to our observations, stem from the disruption of the olfactosome, our studies will link basic
biology to translationally important molecular changes that impair neuronal function.

Public health relevance
Project Narrative Biomolecular condensates (BMCs) are involved in a variety of cellular processes and have an emerging role in neurodevelopmental and neurological disorders. Here, we propose to elucidate BMC principles governing the activation of a single olfactory receptor allele by a multi-enhancer hub in olfactory sensory neurons. With the emerging connection of olfactory deficits and olfactory receptor downregulation with a variety of human pathologies, from Alzheimer’s disease to COVID-19 infection, our experiments will uncover key molecular principles with basic and translational significance.